Neuroeconomic mechanisms of counterfactual thinking

PROJECT SUMMARY / ABSTRACT
There is a fundamental gap in understanding how neurons integrate hypothetical information when making
decisions. This includes not only predicting future outcomes before making choices but also evaluating
consequences of unselected alternatives. These computations serve as the basis of counterfactual thinking and
regret processing. This phenomenon is central to a wide range of cognitive capabilities but whose dysfunction,
despite contributing to numerous psychiatric disorders, is poorly understood. My long-term goal is to uncover the
mechanisms governing counterfactual thinking, how the brain binds hypothetical value to unselected actions,
and how this translates into changes in motivated behavior. This proposal will determine how single neurons in
the nucleus accumbens (NAc) – a critical node of value integration and action selection – support counterfactual
thinking constrained by its known inputs. We will leverage innovative approaches in rodent neuroeconomics that
we developed to capture complex, evolutionarily conserved decision-making processes across species. We will
combine this with cutting-edge brain-wide imaging tools and novel circuit-dissection technologies we developed
to measure circuit physiology at an unprecedented level. Our central hypothesis is that populations of functionally
distinct neurons in the NAc defined by upstream inputs are differentially involved in assigning credit to missed
reward-related opportunities due to different unselected actions. This hypothesis is based on our preliminary
data implicating multiple circuits that converge in the NAc and may play distinct roles in action-specific forms of
counterfactual thinking. This hypothesis will be tested by pursuing two specific aims: 1) Characterize hypothetical
value encoding of NAc neurons defined by their upstream inputs; and 2) Establish a link between afferent activity
in the NAc and action-specific forms of counterfactual thinking. First, single-cell NAc activity categorized by the
structures projecting to them will be recorded during decision-making behavior in mice. We will characterize firing
properties following economic situations known to invoke representations of missed opportunities and will
manipulate their excitability using chemogenetics to alter the impact of decision history on future behavior.
Second, we will record activity of axonal afferent fibers from major excitatory inputs into the NAc simultaneously
with single NAc cells and use optogenetics to manipulate input terminals during distinct action-selection
processes. This approach is innovative because it captures input-output circuit physiology in ways never before
measured in freely behaving animals using our newly engineered open two-color Miniscope. This is significant
because it answers a fundamental biological question: how do single neurons integrate hypothetical value and
assign credit to unselected actions? Furthermore, this work will test competing theories whether counterfactual
thinking derives from a generalized computation for mistake appraisal or instead comprises dissociable, action-
specific processes. Ultimately, this work has the potential to refine our diagnostic nosology of and develop circuit-
based treatments for how emotion-cognition interactions like regret processing go awry in psychiatric disorders.

Public health relevance
PROJECT NARRATIVE Dysfunction in how the brain makes decisions underlies virtually all psychiatric disorders. Here, we seek to leverage innovative approaches in rodent neuroeconomics in combination with new in vivo imaging technologies to determine the neural basis of complex forms of cognition – including counterfactual thinking, or the ability to represent consequences of unselected actions. This work will uncover how neurons integrate hypothetical information and how such processes influence future behavior, providing translational insights into how novel treatments for mental illnesses could be tailored to circuit-specific computational processes.